METABOLISM OF PEPTIDE HORMONES

Cyclo(Histidyl-Proline) is a metabolite of thyrotropin-releasing hormone. It has been suggested by other workers that this peptide plays a role in regulating prolactin secretion in GH cells. The current investigation of the effect of cyclo(His-Pro) on GH cells indicated that it does not affect basal prolactin release or accumulation or the levels stimulated by TRH. cAMP levels in GH cells are elevated by TRH or VIP, but not influenced by cyclo(His-Pro). cGMP levels in GH cells are not affected by either TRH or cyclo(His-Pro). While there is specific binding of TRH to receptors in GH cells, no such receptors for cyclo(His-Pro) are detectable. It is suggested that GH cells are unresponsive to cyclo(His-Pro).